Elucidating the Three-Dimensional Organization of the Human Cerebellar Cortex Using Histological and Ultra-High Resolution Structural MRI Approaches

In this 2-year R21 grant entitled “Elucidating the three-dimensional organization of the human cerebellar cortex
using histological and ultra-high resolution structural MRI approaches”, we will use advanced 3D histology
and ultrahigh resolution multimodal structural MRI techniques to determine the 3D ground truth organization of
the human cerebellar cortex and relate it to 3D structure in the same tissue samples as shown by high resolution
MRI. The cerebellum is a large brain region appended to the brainstem and consisting of a thin three-layer
cerebellar cortex, and underlying white matter. The cerebellum contains three main divisions, the
vestibulocerebellum, the spinocerebellum and the cerebrocerebellum, each which has distinct afferent and
efferent connections, as well as distinct functions. Moreover, these divisions are often differentially affected by
disease states. There have been limited anatomical studies of the intrinsic connections and three-dimensional
architecture of the human cerebellum and specifically the cerebellar cortex, largely due to methodological
constraints in the human. Most of the information about intrinsic connectivity and cerebellar cortical architecture
is derived from rodent and cat models. Emerging information from animal models have indicated considerable
heterogeneity in the cerebellar cortex of the distinct functional divisions of the cerebellum, but this assumption
has never been explicitly tested in the human cerebellar cortex. Anatomical ground truth information about the
human cerebellar cortex in three dimensions and in the different divisions has not yet been achieved. The goal
of the proposed research is to conduct the first detailed histological analysis of the human cerebellar cortex and
relate the results to structural MRI findings and thereby validate MRI results. To accomplish this goal, we will first
use advanced 3D histological techniques such as CLARITY-based tissue clearing and SWITCH
immunohistochemistry to reveal the neuronal organization of the Purkinje cell layer and granule cell layer as well
as the architecture of the Purkinje cell dendrites and granule cell parallel fiber axons in the molecular layer of the
human cerebellar cortex. This work will be performed in samples from the distinct functional regions of the
cerebellum, namely the vestibulocerebellum, the spinocerebellum, and the cerebrocerebellum to determine
whether the neuronal organization and architecture of the processes in the molecular layer differs across these
regions. Second, and in the identical samples used for histological analysis, we will carry out ultra-high resolution
ex vivo multimodal structural MRI analysis to compare structural and diffusion MRI results to anatomical ground
truth in the human cerebellar cortex. These data will provide a histologically validated MRI dataset of the human
cerebellar cortex using state of the art methodologies from both histology and MRI. The elucidation of this human
intrinsic cerebellar cortical connectome will enable the application of multimodal structural MRI to systematically
characterize the architecture of the human cerebellar cortex and its intrinsic connectivity in healthy and clinical
populations.

Public health relevance
NARRATIVE We propose the first histologically-validated and detailed anatomical study using ultra-high resolution MRI of the human cerebellar cortex. The human cerebellar cortex contains the majority of neurons in the central nervous system and is increasingly recognized as being affected in a range of neurological disorders, but there is little detailed knowledge about its anatomical organization, particularly the architecture of the molecular layer. Results will elucidate the three-dimensional anatomical organization of the human cerebellar cortex and relate it to MRI based measures to produce validated methodologies that can be employed translationally to detect structural alterations in clinical populations.